RAPID ACCELERATION OF DIAGNOSTICS AWARD MANAGEMENT - HIV WP2 AWARDS

The National Institutes of Health (NIH) Rapid Acceleration of Diagnostics (RADx®) Tech program was established to accelerate regulatory review and availability of high-quality, accurate, and reliable diagnostic tests. The goal of the latest RADx Innovation Funnel for HIV Diagnostics is to accelerate the development of point-of-care and home-based HIV diagnostic technologies. The contractor should be able to provide pre-award and post-award management support services to the RADx Award Management for HIV diagnostic tests.
Throughout the duration of the RADx Award Management, it is anticipated that 3 projects will be selected for funding.